Targeting PANoptotic pathways for Myelodysplastic Syndromes treatment

Targeting PANoptotic pathways for MDS treatment
Abstract
Myelodysplastic syndromes (MDS) are a heterogeneous group of bone marrow (BM) failure diseases which
develop from mutant clonal hematopoietic stem/progenitor cells (HSPCs). All MDS patients suffer from peripheral
blood cytopenia-related symptoms, and many of them die of cytopenia-associated complications. 30-40% of
MDS cases transform into acute myeloid leukemia (AML) and die within 4–6 months of AML transformation.
Current treatment for MDS is focused on stimulating blood cell production to reduce symptoms and morbidity,
as well as preventing AML transformation. Hypomethylating agents (HMA) are the first choice of therapy, which
induces clinical responses in >50% of patients. However, due to the failure to eliminate MDS-HSPCs, almost all
patients become refractory. Splice inhibitor treatment is in early clinical trials for patients with spliceosome
mutations and shows promising results. The clinical outcomes of MDS patients are still very poor.
Cytopenia in MDS is a result of ineffective hematopoiesis, which is associated with impaired differentiation
and increased programmed cell death (PCD) of mutant HSPCs and an inflammatory BM environment, which
inhibits blood cell production from remaining healthy HSPCs, whereas AML transformation is a result of the
clonal evolution of mutant HSPCs. We found increased PANoptosis in BM samples of most MDS patients,
especially in patients with mutations of splice factors SF3B1 and SRSF2. PANoptosis is a collective term referring
to pyroptosis, apoptosis and necroptosis. RIPK1 is a master regulator of PANoptosis which kinase activity is
required for all 3 types of PCD. In normal hematopoietic cells (HCs), PANoptosis is restricted by TAK1- and
TBK1-mediated inhibitory phosphorylation and Caspase 8 (CASP8)-mediated cleavage of RIPK1. SF3B1 and
SRSF2 are commonly mutated in MDS causing mis-splicing of TAK1 and CASP8, respectively, resulting in
hypersensitivity of HCs to PANoptosis. We found that hematopoietic-specific Tak1 knockdown or Casp8
knockout in mice causes MDS-like disease with a phenotype similar to SF3B1+/K700E and SRSF2+/P95H knock-in
mice. We also found that either HMA or splice inhibitor treatment induces PANoptosis in SF3B1+/K700E and
SRSF2+/P95H HCs. However mutant Lin-c-Kit+Sca1+ HSPCs are relatively resistant to PANoptosis due to the
activation of TBK1. We hypothesize that inhibition of RIPK1 will restore blood cell counts, while inhibition of
TBK1 will help to prevent AML transformation by facilitating the elimination of mutant HSPCs in SF3B1 and
SRSF2-mutant MDS. We want to test such an idea using SF3B1+/K700E and SRSF2+/P95H mice. We will first
determine whether genetic inactivation of Ripk1 can prevent MDS and also whether pharmacologic inhibition of
Ripk1 can restore blood cell counts after MDS develops. We will then determine whether deletion of Tbk1 can
prevent MDS and whether pharmacologic inhibition of Tbk1 can eliminate the mutant HSPCs in combination with
an HMA or a splice inhibitor. Finally, we will test the effect of RIPK1 and TBK1 inhibition on MDS patient samples.
Our study will provide solid conclusions that will translate these new treatment strategies into a clinical trial.

Public health relevance
Narratives: Bone marrow hematopoietic cells in many myelodysplastic syndrome (MDS) patients are hypersensitive to inflection/damage induced PANoptosis due to dysregulation of key regulators of the PANoptotic pathway caused by genetic abnormalities, such as spliceosome mutations. We found that inhibition of RIPK1, a master regulator of PANoptosis, can prevent PANoptosis and restore blood cell counts, while inhibition of TBK1, a negative regulator of PANoptosis, facilitates hypomethylating agent or splicing inhibitor treatment to eliminate the diseased hematopoietic cells. We want to use both animal models and patient samples to determine the effects of RIPK1 inhibition for blood cell restoration in low-risk MDS and TBK1 inhibition to eliminate the mutant hematopoietic cells in high-risk MDS, in combination with a hypomethylating agent or splicing inhibitor.